ExPEC Vaccine Development

PROJECT SUMMARY
The evolution of bacterial resistance to antibiotics is precipitating a medical crisis that will cause
millions of deaths and cost trillions in dollars. A major bacterial driver of resistance is so-called
extraintestinal pathogenic E. coli (ExPEC), a member of the human microbiome that has reached
pandemic status because of its deadly combination of resistance and virulence. ExPEC is now
the leading cause of resistance-related human mortality worldwide. There is no FDA-approved
vaccine, and efforts to identify novel targets for vaccine development have been hampered by the
pleiotropic nature of this bacterium’s pangenome. Using an exhaustive comparative genomics
approach of > 20,000 sequenced strains covering all sequence types, pathotypes, and
phylogenies, we uncovered two high-priority virulence factor targets that met multiple vaccine-
development criteria. Hypothesizing that immunological blockade of the function of these two
factors will provide a one-two punch that prevents critical steps in systemic infection and invasive
disease, we propose here pre-clinical studies aimed at testing the prophylactic efficacy of such
an approach. This includes a comprehensive evaluation of the vaccine’s performance to prevent
three distinct types of ExPEC infection, a thorough optimization of basic vaccine parameters,
innovation around novel adjuvants, and finally, the immunological mechanism of protection.
Successful completion of this project will yield knowledge as to whether targeting factors important
for invasive infection is an effective strategy to reduce or eliminate global ExPEC-induced
mortality and morbidity.

Public health relevance
PROJECT NARRATIVE Pathogenic and antibiotic-resistant E. coli is a leading cause of worldwide morbidity and mortality. The objective of this proposal is to examine the utility of two virulence factor candidates produced by this pathogen to serve as an effective vaccine against E. coli that disseminates systemically. Encouraging pre-clinical results produced herein will provide the necessary data and experimental backdrop to evaluate testing in phased clinical trials.